Critical Analysis of a Rapid 4-compartment Model in Hispanic Adults:Effect of Age and Level of Body Fatness

ABSTRACT
In response to PAR-16-439, Support of Competitive Research (SCORE) Pilot Project Award (SC1), the PI is
proposing a study that seeks to systematically evaluate a rapid 4-compartment (4C) model in a diverse sample
of Hispanic adults. Testing will consist of one visit to the Exercise Physiology Laboratory at Texas A&M
International University. The PI will recruit Hispanic men (n = 150) and women (n = 150) ages 18-79 years in
Laredo Texas for this study. Participants will be block recruited to ensure equal distribution of age, sex, and BMI
groups.
A criterion 4C model will be determined using deuterium oxide for total body water (TBW), dual energy X-ray
absorptiometry (DXA) for bone mineral content (BMC), and underwater weighing for body volume (BV). A rapid
4C model will be determined using DXA for BV and BMC and bioimpedance analysis (BIA) for TBW. The DXA-
derived BV equation recently developed by the PI (1) in a group of young Hispanic adults (18-45 years) will be
utilized to compute BV for the rapid 4C model. Validity will be established by comparing the %Fat, fat mass (FM),
and fat-free mass (FFM) of the rapid 4C model against the criterion 4C model.
The FFM density, (DFFM), bone mineral (MoFFM), total body water (TBWFFM), and residual (RFFM) will also be
calculated in the rapid and criterion 4C model and compared against the cadaver reference values of Brozek et
al. (2). The PI recently revealed that the FFM characteristics of young- and middle-aged Hispanic adults (18-55
years) significantly differs from non-Hispanic Whites and cadaver reference values of Brozek et al. (2). This is a
significant finding since the cadaver reference values of Brozek et al. (2) are employed in stand-alone methods
such as BIA. Nonetheless, further evaluations need to establish whether variations in FFM characteristics exist
among Hispanic adults who vary in age and level of body fatness. Collectively, findings from the proposed study
will help establish whether a rapid 4C model can be used in a diverse sample of Hispanic adults and whether
the assumptions employed in stand-alone assessments such as BIA (73% TBWFFM) are violated.

Public health relevance
PROJECT NARRATIVE / RELEVANCE A rapid 4-compartment (4C) model is a practical clinical method that has potential for widespread use by medical professionals. This study will advance previous research by evaluating the fat-free mass (FFM) characteristics and validity of a rapid 4-compartment (4C) model in a diverse Hispanic adult population. This relates to the mission of NIH by helping acquire new knowledge of FFM characteristics in Hispanic adults, which is currently unknown, and also whether the rapid 4C model can be used by allied health professionals seeking to monitor body composition during the treatment or prevention of obesity.